Spatial Proteomics of osteoarthritis in bones to uncover disease progression

PROJECT SUMMARY / ABSTRACT
There is an urgent need to develop novel and innovative technologies to advance health and therapeutic
interventions and to develop tools for monitoring of disease progression in the musculoskeletal system.
Molecular details of disease and injury of the musculoskeletal system are particularly needed for novel proteomic
assays to monitor disease progression in osteoarthritis or meniscal injury. Our innovative approach includes
development of Mass Spectrometry Imaging (MSI) technologies for joints to spatially visualize proteins of
the extracellular matrix (ECM) and glycans, and to apply deep proteomic profiling of bones. These
technologically novel approaches will also enable us to develop urgently needed molecular assays to assess the
efficacy of interventions. Molecular changes related to age, injury or osteoarthritis (OA) in musculoskeletal
tissues, particularly bone and cartilage, are typically spatially distinct. This is even more evident when
considering temporal and dynamic changes during emerging functional decline. Our national team provides a
unique combination of expertise to develop new, innovative and paradigm-changing tools to investigate bone
diseases, such as OA, age-related changes in bone, and changes induced by injury to meniscus. Dr. Schilling
(Buck Institute) is an expert in proteomics, global bone analysis, senescence and aging, Dr. Alliston (UC San
Francisco) is an expert in orthopedics, bone mechano-biology, and osteoarthritis disease biology, and Dr. Angel
(Medical University of South Carolina, MUSC) is an expert in MSI, spatial ECM proteomics, and glycan biology.
We will employ and optimize state-of-the-art mass spectrometry imaging (MSI) technologies to spatially
resolve molecular changes in tissues (using a molecular readout mass/charge: m/z) in human and mouse
tissue slices monitoring hundreds of analytes simultaneously. These innovative technologies indicate premise to
develop into groundbreaking tools for the orthopedic and musculoskeletal community to investigate bone and
cartilage decline, and to monitor interventive treatments. With this paradigm change, we will be able to image
hundreds or even thousands of molecules simultaneously at 15 to 40 µm spatial resolution. Protein signatures
from the extracellular matrix in human OA knee tissues revealed very advanced disease progression in cartilage
and bone at the inner (medial) side of the knee (with healthier tissue at the outer/lateral side) discovering distinct
novel OA protein targets. These results and novel spatial assays, in combination with deep proteomic profiling
of the bone proteome (>2,000 protein groups), will provide insights into disease mechanisms and allow for
unbiased proteomic monitoring during functional decline of joints and bones. Robust statistical processing is
implemented. As individual lifespans increase across the world, age-related complications are increasing and
develop into a major public health challenge. The unique MS Imaging and Proteome Profiling capabilities of
our team provide major opportunities for the discovery of Novel Disease Targets for therapeutic interventions.

Public health relevance
PROJECT NARRATIVE Molecular details for understanding disease and injury of the musculoskeletal system are particularly needed to develop novel proteomic assays to monitor disease progression in osteoarthritis or meniscal injury. Our innovative approach includes developing Spatial Mass Spectrometry Imaging technologies for joints to spatially visualize proteins of the extracellular matrix and glycans, and applying deep proteomic profiling for bones using robust statistical tests. These technologically novel approaches will also facilitate the development of urgently needed molecular assays to assess efficacy of interventions for the musculoskeletal system.